Project 3: Immune regulation by cellular glycosylation for the inhibitory antibody development to factor VIII in hemophilia

PROJECT 3: SUMMARY
A major obstacle in treating hemophilia A is that ~25% of patients develop high-titer, neutralizing anti-factor VIII
(FVIII) antibodies (inhibitors) following protein replacement therapy. It is also anticipated that this problem will
occur following gene therapy in at least a subset of patients. It is particularly challenging to treat hemophilia
patients who have developed inhibitory antibodies. Bypassing therapies that are used to treat these patients
sometimes have limited efficacy and are very costly. The anti-FVIII inhibitory antibody formation results from a
complex multifaceted immune response involving both genetic and environmental risk factors. Several “danger
signals” have been demonstrated to be associated with risks of inhibitor formation. However, the potential
triggers to activate anti-FVIII responses are not fully understood. For example, patients with identical mutations
in FVIII gene can have differential risks in inhibitor development following protein replacement therapy.
Moreover, there were some implications that different FVIII products may exhibit different degrees of inhibitor
risks. In recent years, it has been demonstrated that glycans are crucial for the immune system, as some of the
most important interactions between the immune system and viruses or bacteria or exogenously added
proteins are mediated by protein-glycan interactions. Glycosylation is involved in almost every step of the
immune activation pathway. Glycans are a key in the recognition of non-self events and an altered glycome
can lead to activation of immune responses. Glycosylation is also involved in the cellular mechanisms that
control the threshold of TCR activation, immune cell trafficking, TCR and BCR signaling, antibody function, and
more. We hypothesize that the impact of glycans in the induction of immune response or tolerance to FVIII can
be twofold: one is that the interaction of glycosylated FVIII antigens and host immune system with specific
glycan profiles can be significant in determining the risk of inducing anti-FVIII immune response; and the
second is that the recognition of and ensued immune activation by exogenously added protein or gene
expression can be altered by different extent or patterns of FVIII glycomes. Therefore, in order to more fully
understand the spectrum of potential glycosylation influence on the development of anti-FVIII inhibitor
responses, we propose to first look into the influence of host glycan profiles in the development of anti-FVIII
response both in humans and mice with different backgrounds. Next we will characterize the immune
responses elicited by delivery of FVIII molecules with different extent or patterns of glycosylation and
investigate the mechanism of immune activation. From this study, we wish to define specific immunologic
trigger by glycosylation and its associated mechanisms, leading to prevention or elimination of FVIII inhibitors.